Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center

An excess burden of chronic kidney and end stage renal disease is experienced by Black Americans.
Risk variants in the apolipoprotein-1 (APOL1) gene, found almost exclusively in individuals of African ancestry,
are associated with several forms of non-diabetic kidney disease in Black Americans, including focal
segmental glomerulosclerosis, HIV-associated nephropathy, and hypertension-related kidney disease. These
APOL1 risk variants explain up to 70% of the excess risk in Black Americans with these kidney diseases.
However, presence of these risk variants does not guarantee development of kidney disease, with secondary
genetic or environmental hits required. This along with lack of targeted therapies makes the value of genetic
screening for APOL1 risk variants unknown. The impact of APOL1 risk variants in kidney transplantation, for
both donors and recipients, is understudied. It is unknown if living kidney donors with APOL1 risk variants are
at increased risk for development of kidney disease post donation. For recipients, initial studies have
suggested that recipients who receive donor kidneys with two APOL1 risk variants may have worse graft
outcomes. Due to both biological and social-economic factors, Black Americans have been historically
disadvantaged in receiving kidney transplants, and the theoretical practice of APOL1 genetic screening and
excluding donors with risk variants could further disadvantage this population. These multiple questions
highlight the need to thoroughly examine the impact of APOL1 risk alleles on transplant outcomes. The NIH-
sponsored APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) is addressing this
important question by uniting transplant centers, organ procurement organizations (OPOs), and the United
Network for Organ Sharing (UNOS) to enroll donors of African ancestry and their kidney recipients, then follow
their transplant outcomes. In Phase 1 of APOLLO, we have functioned as an ideal clinical center in direct
response to original request for application by enrolling 154 qualifying deceased donor recipients, living
donors, and living donor recipients through partnerships with 8 transplant centers in addition to our primary
Vanderbilt University Medical Clinical Center, providing DNA, biospecimens, and essential longitudinal clinical
data. Our aligned transplant centers include large academic programs as well a small community programs to
strive for the goal of universal enrollment. We have worked seamlessly with the other Clinical Centers and the
SDRC, as well as partnered with OPOs and UNOS, to build a strong foundation for APOLLO. For Phase 2, we
will continue the important work of the APOLLO Consortium through accomplishment of several aims. In Aim 1,
we will prospectively collect long-term follow-up data on all APOLLO participants and enroll additional living
donors. In Aim 2, we will provide detailed clinical data and biospecimens on APOLLO participants as well as
kidney transplant biopsy slides from our Clinical Center. In Aim 3, we will facilitate return of APOL1 genotype
results. Once completed, these Aims will advance our knowledge of APOL1 in kidney transplantation.

Public health relevance
APOL1 genetic risk variants, found almost exclusively in individuals of African ancestry, are associated with non-diabetic kidney disease in African Americans, explaining up to 70% of the excess risk for kidney disease seen in this population. Given that kidney transplantation is the preferred treatment for the individuals who progress to end stage kidney disease, knowledge about the impact of APOL1 risk variants on kidney transplant outcomes for both living donors who have the variants and the recipients who receive donor kidneys with the variants is essential. This knowledge will lead to better informed consent, improved organ allocation, and plausibly improved clinical outcomes for both donors and recipients.